Evaluation of the Presumptively Initiating Vaccines and Optimizing Talk with Motivational Interviewing (PIVOT with MI) Intervention

PROJECT SUMMARY
This proposal addresses a significant public health problem—parental vaccine hesitancy and refusal—for
which there are currently few well-designed and rigorously evaluated interventions. National estimates of the
percentage of 19 – 35 month old children who are up-to-date on recommended vaccines remain below Healthy
People 2020 goals. A key contributor to under-immunization is parental refusal or delay of vaccines due to
vaccine concerns. Vaccine-hesitant parents (VHPs), a large, diverse group of parents who refuse and/or delay
at least one recommended vaccine for their child, are an important population for interventions aimed at
improving vaccine acceptance. While VHPs’ most trusted source of information is their child’s provider,
providers lack confidence in communicating with VHPs and often perceive their discussions will do little to
change a parent’s mind. Improved provider communication with VHPs is therefore critical to
improving childhood vaccine uptake and preventing outbreaks of vaccine-preventable disease.
However, there is a lack of experimental evidence for specific communication strategies for providers. In
preliminary work, Opel et al. found that provider use of a presumptive (e.g. “Well we have to do some shots.”)
rather than a participatory (e.g. “How do you feel about vaccines today?”) communication format to initiate
the vaccine recommendation was associated with increased parental vaccine acceptance. This presumptive
format, though, may lead to decreased parent satisfaction, raising concerns that a presumptive initiation will
result in decreased vaccine uptake over time. In separate work, O’Leary et al. explored the use of Motivational
Interviewing (MI) to increase uptake of HPV vaccine recommended for adolescents. Motivational Interviewing
is a patient-centered framework for behavior change that contains elements that are consistent with known
communication preferences of VHPs regarding vaccines. O’Leary et al. found that provider use of MI in
discussions with parents who resisted the HPV vaccine recommendation resulted in increased parental vaccine
acceptance and improved provider perceptions of their ability to influence parental vaccine decision-making.
In this proposal, O’Leary and Opel aim to combine these two techniques—the Presumptively
Initiating Vaccines and Optimizing Talk with Motivational Interviewing (PIVOT with MI)
intervention—to achieve increased vaccine uptake, high parent visit satisfaction, and improved
provider confidence in the vaccine conversation. Our specific aims will be to (1) develop a multifaceted,
feasible, and culturally appropriate PIVOT with MI intervention provider training program; (2) evaluate the
impact of the PIVOT with MI intervention on child immunization status at 19 months of age by randomizing 24
primary care practices in 2 states (Washington and Colorado) to control or intervention arms using a cluster
randomized design; and (3) evaluate the impact of the PIVOT with MI intervention on parent and provider
experience.

Public health relevance
PROJECT NARRATIVE A child’s health care provider is the most important influence on parental vaccine decision-making. Provider communication with parents about vaccines is therefore critical to addressing parental vaccine hesitancy. The overall goal of this project is to evaluate the impact of a novel and innovative provider communication strategy on vaccine acceptance among vaccine-hesitant parents.